Computational Dissection of Neural Circuit Mechanisms Underlying Anticipatory Anhedonia in Schizophrenia

Abstract: Anhedonia, characterized by the inability to experience pleasure, poses a significant challenge in
schizophrenia. This is due to the lack of effective treatments and its association with severe cognitive deficits.
However, the neural circuitry underlying anhedonia remains poorly understood, hindering the identification of
treatment targets. Anhedonia in schizophrenia is often expressed as a deficit in reward anticipation
(anticipatory anhedonia). Here we propose an innovative computational psychiatry approach to dissect the
neural circuitry underlying altered reward anticipation. This will give insights into how anhedonia links to
cognitive deficits in schizophrenia. Furthermore, our study will also advance our understanding of the
underexplored transdiagnostic NIMH RDoC construct: reward anticipation.
We will utilize the behavioral economics notion of anticipatory value computation, a concept that has
not yet been applied to understand psychiatric conditions. Unlike existing approaches, our framework offers
(1) a computational model that quantitatively predicts the behavioral and neural correlates of dynamic reward
anticipation processes and (2) a new experimental paradigm for measuring anticipatory value signals in the
brain and the behavioral manifestations. We recently validated this framework in task-based fMRI experiments
with healthy volunteers, successfully identifying the neural circuitry associated with reward anticipation.
Building upon our recent findings, we hypothesize that an altered functional coupling between the
hippocampus and the dopaminergic midbrain underlies anticipatory anhedonia, a novel, untested hypothesis.
We will test our hypothesis with two sets of studies: (1) large-scale online experiments, and (2) fMRI
experiments with individuals with schizophrenia and matched healthy volunteers. First, we will establish the
relationship between anticipatory value computation and anhedonia traits within a large diverse online sample,
by examining task behavior and self-reported questionnaires. Second, we will identify the neural circuitry
involved in altered anticipatory value computation using model-based fMRI analysis. We will explore
alternative hypotheses including the altered hippocampus-prefrontal cortex coupling. Third, we will examine
whether the neural alterations responsible for anhedonia could also account for cognitive deficits.
Our studies will uncover neural circuit alterations underlying reward anticipation deficits, which may
serve as novel targets for treating anhedonia and cognitive deficits in schizophrenia. Furthermore, our study
will contribute to developing a new task-based computational framework, which can identify potentially distinct
reasons for altered reward anticipation and anhedonia. Thus, our computational and experimental framework
has the potential to develop novel personalized treatment interventions for individual patients, e.g., with
connectivity-based neurostimulation approaches.

Public health relevance
NARRATIVE Anhedonia in schizophrenia is a major public health concern due to the lack of established treatments and its association to severe cognitive deficits. In this proposal, we aim to develop a novel computational and neuroimaging framework to identify the neural circuitry dynamics underlying anhedonia in schizophrenia. This study will offer a novel computational and task-based framework for objectively identifying individual variations in the neural deficits underlying anhedonia and other major symptoms in schizophrenia, which will aid in the development of personalized treatment strategies and reduce the harmful stigma associated with diagnosis.